CE25-021 - Implementation and Impact of School Cellphone Policy on School and Community Violence in Michigan

PROJECT SUMMARY/ABSTRACT
Social media (SM) use is associated with disengagement from school and poor mental health, and can
facilitate inter-personal and community violence, including cyber-bullying which is highest among LGBTQ+
adolescents (25%) and female (21%) students. Digital apps have been used to document and share
recordings of fights, create escalation of conflicts, and be used to create direct and indirect threats. Given
these negative impacts, a number of school districts across the country have implemented policies that
monitor, restrict, or ban cellphone use in schools. Policies vary greatly both in their objectives and
enforcement. Despite the ubiquity of such policies, there are no studies that explore how effective cellphone
bans are at reducing school- and community-based violence let alone their potential unintended consequences
such as limiting the ability of students to report concerns about themselves or others. The proposed project will
examine school cellphone policies in Michigan using a mixed method approach to assess both implementation
and impact, with a particular focus on how such policies differentially impact communities of color across the
state. This research falls under CDC Research Objective #1 (effectiveness research to evaluate innovative
approaches for reducing community violence) and has direct policy implications for districts in Michigan and
across the country seeking to restrict school cellphone use. Using a combination of interview, survey, and
administrative data sources, researchers will describe state-level variability in district student cellphone
policies, understand the barriers to and facilitators of implementation and estimate their impact on indicators of
community violence, including fights in school, school discipline, and police incidents. The impact analysis will
utilize several quasi-experimental methods including difference-in-difference and comparative interrupted time
designs to estimate causal impacts of the policy. Leveraging rich administrative data on school- and
community-based violence along with youth demographics and community characteristics from the Michigan
Department of Education and the Michigan State Police will allow researchers to control for a variety of
potentially confounding factors and study critical outcomes at the school level. Importantly, access to this type
of individual-level outcome data will allow the researchers to convincingly assess if and how cellphone policies
differentially affect racial/ethnic groups and other important subgroups (e.g., urban, suburban and rural
schools). Moreover, this data will allow us to study how the cellphone policies impact mental health and
academic outcomes and examine whether these effects mediate impacts on violence.

Public health relevance
PROJECT NARRATIVE This mixed-method study examines school cellphone policies in Michigan, seeking to not only understand how they impact school- and community-based violence overall, but also explore the differential impact of such policies by race/ethnicity and community characteristics. Using a combination of interview, survey, and administrative data sources, researchers will describe state-level variability in district student cellphone policies, understand the barriers to and facilitators of implementation and estimate their impact on indicators of community violence, including fights in school, school discipline, and police incidents. Analysis will also examine whether implementation fidelity moderates policy impacts and test whether mental health and academic outcomes mediate the policy effect on school and community violence.